Core Services: Division of Immunology, Flow Cytometry Core

Abstract ? Flow Cytometry Core Flow cytometry is a powerful technology that has revolutionized biomedical research and become an integral investigative tool for research across diverse disciplines. The Flow Cytometry Core at TNPRC provides analytical flow cytometry services and live cell sorting under enhanced Biosafety Level 2 (BSL2+) conditions and is managed by the Division of Immunology. The core personnel are responsible for all flow cytometry sample acquisition and cell sorting experiments performed at TNPRC. The core is heavily utilized and supports research projects of at least 25 TNPRC core scientists and more than 30 affiliate scientists. The Flow Cytometry Core will continue to expand its capability to keep abreast with state-of-the-art technology and maintain its high standard of service.